Impact of sensory impairments on movement in children with cerebral palsy

PROJECT SUMMARY
Cerebral palsy (CP) is the most common pediatric neurological disorder. CP is caused by damage to
brain areas during development. CP results in weakness, altered tone and abnormal coordination. In unilateral
spastic CP (USCP), the damage has a unilateral predominance. Although CP is defined as a motor disability,
approximately 80% of people with USCP have deficits in sensation that limit the extent of rehabilitation. There
is a poor understanding of how the sensory and motor systems interact in children with USCP. Impairments in
motor and sensory function have largely been studied in isolation (rather than together) in children with USCP,
even though voluntary movement requires the integration of sensory and motor processing. Moreover, while
the motor system is better-characterized, there is still a limited understanding of how the location, type, and
size of a child’s lesion impacts sensorimotor processing. There is an urgent need to identify and quantify
sensory factors that impair movement in children with USCP.
Our long-term goal is to develop evidence-based ways to improve movement in children with USCP.
The overall objective for this project is to determine how fine touch sensation and sensation of limb position
contribute to movement deficits in children with USCP. To meet our goal, we must not only know how sensory
systems impact impairment in movement, but we must determine how a child’s lesion and brain connectivity
contributes to these impairments. Our central hypothesis is that sensory dysfunction plays a key role in the
ability of children with USCP to engage in functional, skillful movements. We also hypothesize that damage to
specific brain regions cause specific kinds of impairments. The rationale for the proposed work is that
demonstration of a strong relationship between sensory impairments and movement deficits will steer the
development of therapies that engage children in the use of sensory information during meaningful complex
tasks, with the goal of boosting motor function.
!

Public health relevance
PROJECT NARRATIVE Unilateral cerebral palsy is an extremely common pediatric neurological disorder, and is defined as a disorder of movement. The goal of the proposed studies is to test the novel hypothesis that sensory system impairments contribute to movement deficits. Understanding how sensory and motor systems interact in children with CP will provide important insights into how to develop novel therapies that target the root of a child’s impairments.